Core A - Administration

Core A: Administrative Core Abstract The Administrative Core (Core A) will provide the structure for the overall program and will facilitate interactions between the five Projects and the Virogenomics & Biostatistics Core B. It will provide the scientific leadership for the whole program and will guide the scientific exchange between all the components in the program. Core A will also provide fiscal support for all projects and cores, and organizational support for the regular scientific meetings of the project and core leaders, as well as the external advisory board. In summary, Core A will promote programmatic interactions and foster the exchange of information and reagents to ensure all aspects of a successful and productive program project.

Public health relevance
Core A: Administrative Core Narrative The Administrative Core (Core A) will provide the structure for the overall program and will facilitate interactions between the five Projects and the Virogenomics & Biostatistics Core B. It will provide the scientific leadership for the whole program and will guide the scientific exchange between all the components in the program. Core A will also provide fiscal support for all projects and cores, and organizational support for the regular scientific meetings of the project and core leaders, as well as the external advisory board. In summary, Core A will promote programmatic interactions and foster the exchange of information and reagents to ensure all aspects of a successful and productive program project.